MINORITY RESEARCH PROGRAM ANALYTIC SUPPORT

This unit will provide a common coordinating and analytic resource for all studies funded through the above procurements. Specifically it will: 1) provide statistical consultation to all participating study investigators; 2) perform quality control checks on data collection, processing and analyses performed by the participating investigators; and 3) foster an ongoing exchange of information between investigators and mutual problem solving of major research issues that arise, and (4) logistical support to NCI.